A novel exon-specific U1 snRNA strategy to correct splicing in Familial Dysautonomia

Familial dysautonomia (FD) is a recessive neurodegenerative disease caused by a splice mutation in the IKBKAP gene that leads to tissue-specific variable skipping of exon 20. This, in turn, leads to a drastic reduction of IKAP/ELP1 protein in the central and peripheral nervous system. Although FD patients suffer from multiple neurological symptoms, progressive blindness drastically reduces quality of life and is a major concern of patients and their families. In this proposal, we outline a novel strategy to target mRNA splicing in the retina as a potential therapy for retinal degeneration in FD. Dr. Franco Pagani's laboratory has developed novel modified versions of the spliceosomal U1snRNAs (ExSpeU1s) that can be specifically targeted to improve inclusion of skipped exons. This strategy has proven successful in several other splicing disorders, including spinal muscular atrophy and cystic fibrosis. Recently, his lab has created IKBKAP specific U1s with precisely targeted base- pairing and together we have shown that they correct splicing and increase IKAP protein both in FD cells and in vivo by intraperitoneal delivery using AAV9. For the past several years, we have worked to generate a new FD mouse model that both recapitulates the human disease phenotype and the tissue-specific splice defect. Our new mouse is the only model that can be used to evaluate the therapeutic effect of IKBKAP splicing modulation on disease phenotype. Mutations that alter mRNA splicing account for a large fraction of all human genetic disease, and methods to correct splicing, including small molecules and oligos, are already in clinical trials. mRNA splicing is a complex process, and therefore it is impossible to predict the efficacy of these methods across various mutations, and in fact it is likely that combination therapies will ultimately be necessary. In this proposal we will study a novel therapeutic strategy, namely the delivery of exon-targeted U1 snRNAs, and we will test their efficacy specifically in the retina given the speed with which AAV directed gene therapy for retinal disease is moving into the clinic. We have assembled an expert team and our studies will not only address a critical unmet medical need in FD but will also allow us to uncover the precise mechanism by which these exon targeted molecules correct splicing. Successful completion of the stated Aims will certainly have implications for treating genetic splicing disease beyond FD, further increasing the significance of this proposal.

Public health relevance
In this grant, we will explore the therapeutic potential of a new targeted approach to modulate splicing in Familial Dysautonomia using modified U1 snRNA molecules. Treating progressive blindness represents a significant unmet medical need in FD, as it has a devastating effect on the quality of life of patients. In this grant we will characterize the progression of retinal degeneration in our new FD mouse model and explore the therapeutic potential of restoring exon 20 inclusion using gene-targeted U1 molecules.